Mechanism of Notch inhibition resistance in glioblastoma stem cells

ABSTRACT
The goal of this proposal is to explore the mechanism of Notch inhibition resistance in
glioblastoma (GBM) in order to develop novel therapy for this deadly disease. Cancer Stem-
like cells (CSCs) are thought to be critical for the engraftment and long-term growth of GBM.
They are at least partially spared by traditional chemo- and radiation-therapies, and ﬁnding
new treatments to target CSCs may be critical for improving patient survival. We recently
demonstrated that Notch pathway blockade by gamma-secretase inhibitor (GSI) depleted
CSCs, inhibited neurosphere growth in vitro and propagation in vivo, and prolonged the
survival of mice bearing the intracranial xenografts. A subsequent Phase I clinical study
showed that 24% malignant glioma patients responded well to GSI treatment and have
stabilized disease for more than four months. Another Phase I trial showed that GSI indeed
cross the blood brain barrier (BBB) and reduce Notch activity in treated GBM CSCs.
However, the molecular mechanism of GSI treatment resistant in GBMs are largely
unknown. One main possible mechanism of GSI resistance is different genetic
background of GBM, such as status of PTEN, may result in different responses to GSI.
Our preliminary data showed that GBM with loss of PTEN resistant to GSI treatment.
Interestingly, we found that Akt inhibitor can reduce these GSI-resistance GBM
neurospheres propagation in vitro and in vivo. We hypothesize that GBM with wild type of
PTEN will be sensitive to GSI treatment and that GBM with loss of PTEN will be sensitive to
pAkt inhibition. In the present proposal, we will identify GBM patient subsets that will be
beneﬁt from Notch pathway inhibition or Akt inhibition in term of targeting CSCs based on
individual genetic background. To test our hypothesis, we will pursue the following
specific aims:
Aim1: Deﬁne the mechanism of targeting GBM CSCs by Notch pathway blockade
based on tumor's genetic background of PTEN.
Aim2: Examine a combination of Notch inhibitor and pAkt inhibitor plus chemo-
and radiation-therapy in a pre-clinical GBM intracranial xenograft mouse model.
Success in this proposal will enhance our understanding of glioblastoma biology and
have signiﬁcant impact on GBM therapy.

Public health relevance
PROJECT NARRATIVE: We have demonstrated that Notch pathway blockade by gamma-secretase inhibitor (GSI) depletes glioblastoma cancer stem cells and prolong survival in mice bearing intracranial glioblastoma xenografts. NIH supported phase I clinical trials using GSI to treat malignant glioma patients based on our published data and two phase I clinical trial reports showed that GSI indeed cross the blood brain barrier and target glioblastoma stem cells, and that 24% malignant glioma patients have stabilized disease for more than four months. In the current proposal, we will investigate the mechanism of GSI resistance in glioblastoma stem cells in order to develop additional novel therapy for this deadly disease.